LXR-Dependent Cholesterol Sensing

Project Summary:
Non-alcoholic fatty liver disease (NAFLD) is estimated to affect 25% of the adult population in the United
States and approximately 25% of NAFLD patients progress to non-alcoholic steatohepatitis (NASH),
characterized by liver inflammation, hepatocyte ballooning, and fibrosis. Importantly, NASH increases the risks
for cirrhosis, hepatocellular carcinoma, and liver failure. The processes that trigger the progression of NAFLD
to NASH or even if there is a true stepwise progression from one pathological state to the other remain to be
determined. NAFLD is associated with increases in liver triglycerides and elevated rates of fatty acid synthesis.
Nevertheless, since most NAFLD patients do not have NASH, it is not clear if elevated fatty acids alone are
sufficient to promote inflammation and fibrosis. Cholesterol is also increased in the livers of patients with NASH
and non-esterified cholesterol correlates with disease severity. We reasoned that a unique approach to
unraveling the roles of cholesterol in chronic liver diseases would be to reversibly disrupt cholesterol sensing.
Liver x receptor alpha (LXRα) functions as an important cholesterol sensor that regulates hepatic fat and
cholesterol metabolism at the transcriptional level in response to the direct binding of cholesterol derivatives.
To disrupt cholesterol sensing we have generated mouse lines that change tryptophan 441 of LXRα to
phenylalanine (W441F). W441F disrupts binding of endogenous cholesterol derived LXR ligands while still
allowing transcription regulation by potent synthetic agonists providing a unique tool that blocks the ability of
LXRα to sense cholesterol while still allowing pharmacological control.
When fed a high fat/high cholesterol diet LXRα W441F mice rapidly (within 4 weeks) develop
pathologies associated with NASH. Strikingly W441F mice have decreased hepatic triglycerides but large
increases in cholesterol. Therefore, NASH-like phenotypes can arise in the absence of elevated hepatic
triglycerides (“cholesterol-dependent NASH”). We hypothesize that decreased LXR activity in W441F
hepatocytes leads to cholesterol accumulation which serves as the initiating event promoting
inflammation and fibrosis. Furthermore, we propose that elevated hepatic cholesterol promotes NASH, at
least in part, via cholesterol-dependent activation of the transcriptional coactivator with PDZ binding motif
(TAZ, Wwtr1). TAZ is over expressed in livers of human NASH patients and promotes inflammation and
fibrosis when over expressed in mouse models. Finally, our ability to re-establish LXR activity in W441F
mice using pharmacological agents provides a unique opportunity to determine if cholesterol-
dependent NASH can be reversed. Taken together our proposed studies will provide new insights into the
mechanisms by which elevated cholesterol levels contribute to the pathogenesis of NASH and other chronic
diseases.

Public health relevance
Project Narrative: High levels of cholesterol are linked to many chronic diseases including heart disease, type II diabetes and fatty liver disease. We have generated novel mouse models where cells in the body have lost the ability to respond to changes in cholesterol. When fed a high cholesterol diet these mice rapidly develop liver disease and will provide a new model system to study how cholesterol influences many chronic diseases.